Neuronal Vulnerability to Lipid Droplets and Cholesterol in Alzheimer's Disease

ABSTRACT
Alzheimer's disease (AD) is a devastating neurodegenerative disorder that afflicts over 6.5 million Americans.
Despite decades of research on amyloid-β (Aβ) and Tau lesions, effective treatment remains out of reach.
Mounting AD genome-wide association studies (GWAS) risk loci provide opportunities for understanding
disease biology and developing effective treatment. Multiple AD GWAS risk genes, such as APOE, are pivotal
for lipid metabolism that is essential to brain health and disease. Under stress or in the aging brain, both
astrocytes and microglia show abnormal lipid metabolism and accumulation of lipid droplets (LD). Although
glial LD are known to be largely neuroprotective, LD formation in human neurons and its cellular and molecular
ramifications are less clear. With excitatory neurons (Ex) derived from human induced pluripotent stem cells
(iPSC), we have shown that APOE4 Ex neurons co-cultured with astrocytes accumulated more LD than
APOE2/3 neurons. Our single-cell transcriptomic analysis of AD brain also identified an impaired neuron-
oligodendrocyte precursor cell (OPC) communication mediated by APOE and its receptor LDLR. Interestingly,
neural cholesterol was recently found to be essential to OPC proliferation and remyelination. We thus
hypothesize that abnormal neuronal LD and cholesterol in AD contribute to neuronal damage and impaired
neuron remyelination. Leveraging our expertise on using iPSC-derived neurons and cortical organoids as
cellular models for brain disorders, we will characterize the cell type vulnerability to LD/cholesterol and the
corresponding epigenomic/transcriptomic changes in the context of AD risk alleles. In Aim 1, to determine the
neural vulnerability to LD and its clinical relevance in AD, we will co-culture Ex and Inhibitory (Inh) neurons of a
cohort of 60 patient-specific iPSC lines, and assay neural LD, free fatty acids, cholesterol, and neural
morphometrics, which will then be associated with APOE alleles and non-APOE AD polygenic risk scores.
These cellular phenotypes will also be correlated with patients’ longitudinal plasma lipid levels and other
clinical outcomes. In Aim 2, to understand molecular mechanisms underlying neural vulnerability to LD, we will
perform single-cell RNA/ATAC-sequencing on the same neural co-cultures used in Aim 1 to identify genes with
chromatin accessibility and transcription correlated with cellular LD in each cell type. In Aim 3, to examine the
effect of AD risk alleles on cholesterol-mediated neuron-OPC communication and myelination, we will first use
CRISPR editing to generate isogenic iPSC lines carrying AD risk alleles and then differentiate them into
myelinating cerebral organoids. We will examine the effects of AD risk alleles on neuronal cholesterol levels as
well as the OPC proliferation and neuron myelination. This study will significantly advance our understanding of
the cellular and molecular mechanisms of neuronal vulnerability to abnormal LD and cholesterol in AD.

Public health relevance
NARRATIVE This study will determine neuronal vulnerability to lipid droplets (LD) and cholesterol, and the underlying molecular changes associated with Alzheimer's disease (AD) risk alleles. The results will significantly advance our understanding of how cell type-specific abnormal LD and cholesterol contribute to AD risk, which will help identify cellular biomarkers for AD progression and help develop more tailored lipid-based treatments.